Tracking and Evaluation Core

The Tracking and Evaluation (TE) Core has the mission to support the leadership and programs of the
Oklahoma Shared Clinical and Translational Resources by assessing progress toward stated goals and
improving the effectiveness and efficiency of OSCTR core strategies. The overall commitment to evaluation is
demonstrated by the integration of tracking and monitoring activities throughout each OSCTR core and their
specific aims. The TE Core built logic models for each core with measurable outcomes that have been
invaluable in both strategic planning and evaluation for the OSCTR. Infrastructure was developed to facilitate
activity tracking and evaluation that provides support and service to the OSCTR, as well as other large
institutional grants. Further, the TE Core has helped to assess large programs of the OSCTR by completing in-
depth evaluation studies of major OSCTR activities, including Pilot Projects Program, Summer Research
Training Program, and Translating Practice into Research. These assessments have identified key refinements
to improve programs, as well as identifying underperforming processes. Our approach to evaluation has
focused, and will continue to focus, on process and outcome measures in which OSCTR leaders and
participants are active in prioritizing, framing, capturing, and using for overall program improvement. The TE
Core will continue to evaluate the overall operational functions and outcomes of the OSCTR cores through
assessment of short- and long-term goals, monitoring program implementation, and tracking resource
utilization. However, this renewal offers a critical opportunity for the TE Core to move beyond process metrics
and the measurement of short-term objectives, to address efficiency, quality, and impact of OSCTR strategies
through enhanced tracking mechanisms involving bibliometric analyses, return on investment calculations, and
social network analyses. The TE Core will continue to work with the Tracking and Evaluation Cores of the other
IDeA-CTR awardees to share best practices and lessons learned through the evaluation activities of these
centers and to utilize those findings to improve the overall processes and outcomes of the OSCTR. Finally, the
TE Core is committed to helping accomplish a major objective of the OSCTR to establish the next generation
of scientific leaders at our partners by continuing the professional development of a promising young
investigator through the evaluation activities of this core.